Discovery and therapeutic targeting non-coding RNAs in T1D- or T2D-associated atherosclerosis

Despite current therapies and prevention measures, individuals with type 1 diabetes (T1D) experience a
disproportionately higher risk of cardiovascular events due to a more severe and accelerated atherosclerotic
burden present in vessels, a longer duration of diabetes exposure, and often asymptomatic early disease that
can lead to sudden cardiac death as the first manifestation of disease compared to patients with type 2
diabetes (T2D) or those without diabetes. Moreover, established lesions in the presence of T1D are more
resistant to therapeutic strategies (diet or pharmacologic lipid-lowering) that normally facilitate plaque
regression. Therefore, there is an urgent need for novel therapies to reduce the development of T1D-
associated atherosclerosis that can lead to cardiovascular sequelae. Current paradigms suggest that chronic
inflammation coupled with sustained endothelial inflammatory responses, altered macrophage chemotactic and
efferocytotic functions, and accumulation of senescent cells may be critical links to the accelerated lesion
progression and impaired regression with T1D. Therefore, targeting these processes in the vessel wall may
provide a novel therapeutic approach to limit atherosclerotic progression and facilitate regression. However,
significant gaps remain in the molecular underpinnings that regulate T1D-associated atherosclerotic
pathobiology with limited studies derived from human coronary arteries. A large portion of the non-coding
genome is actively transcribed and constitute microRNAs (miRNAs) or long non-coding RNAs (lncRNAs).
Studies from our laboratory have uncovered novel cell-specific roles for a range of miRNAs and lncRNAs in
regulating key endothelial cell-leukocyte inflammatory networks in atherosclerosis, such as NF-kB signaling.
Considerable gaps exist though in our understanding of how human ncRNAs contribute to accelerated
atherosclerosis and differences in T1D and T2D. We hypothesize the existence of evolutionarily conserved
driver ncRNAs and their targets in the arteries of subjects with T1D and T2D and seek to uncover their
expression, function, mechanism, and interactomes in the Cardiovascular Repository-T1D (CaRe-T1D) using
unique approaches across humans, pigs, and mice. To better understand these ncRNAs we propose to: 1)
identify and prioritize ncRNA expression from human subjects with T1D- or T2D-associated atherosclerotic
lesions; 2) explore the functional significance and mechanistic targets of ncRNAs on cellular inflammation,
senescence, and metabolic pathways; and 3) determine the therapeutic impact of altered ncRNA expression in
the progression and regression of experimental T1D- or T2D-associated atherosclerosis models. The
outstanding qualifications of our multi-disciplinary team in the ncRNA field, vascular biology, bioinformatics and
transcriptomics, molecular imaging, and translational aspects of diabetes-associated atherosclerosis uniquely
position us to establish an unprecedented molecular view of ncRNAs in the development of T1D-associated
atherosclerosis that can inform new paradigms of RNA-based therapeutics for this devasting disease.

Public health relevance
Narrative: Patients with type 1 diabetes (T1D) suffer a disproportionate higher risk of atherosclerosis and its consequences (e.g. heart attacks) remain the leading cause of morbidity and mortality in these patients. Emerging studies demonstrate important regulatory roles for non-coding RNAs in atherosclerosis, yet this is a poorly understood area of research in T1D. Our studies aim to fill this void by investigating the roles of key non-coding RNAs and their target genes and interactomes in cellular events important in the progression and regression phases of T1D-associated atherosclerosis, with the ultimate goal of developing innovative RNA-based therapies in the treatment of this devastating disease.